Reproducibility in simulation-based prediction of natural knee mechanics

PROJECT SUMMARY
Simulations of knee biomechanics are increasingly utilized to develop individualized and actionable knowledge
regarding healthy homeostasis, impact of musculoskeletal diseases, and risk of injury. Computational modeling
is also appealing to predict performance and safety of implants, and informs surgical tissue reconstruction and
rehabilitation strategies. This is a natural result of the ubiquity of modeling and simulation in biomedicine, and it
is motivated by the knee being a primary concern in musculoskeletal healthcare. However, start-to-end and turn-
key examples of mechanistic simulations, to accelerate biomedical discovery and to routinely inform clinical care,
are scarce. In knee biomechanics specifically, the compelling promise of modeling and simulation has not been
fulfilled. Delivery of computational models and their intended utilization require many operations that collectively
define the modeling and simulation workflow. Variations in the modeler’s choices and the ambiguity of their
implementation introduce uncertainties that impact reproducibility across the modeling and simulation lifecycle,
from intermediate products to end-point simulation results. Reproducibility is essential to the broader credibility
of modeling practices. Its absence within an acceptable threshold, as dictated by the model’s intended use, is a
significant barrier for adoption of simulation. Scalable uses of knee models are also impeded by the burden of
modeling and simulation activities and a lack of specialized guidance. In the past award period, we documented
the art of modeling and simulation in knee biomechanics. Starting with the same data and with the intent to
simulate the same model use cases, five teams demonstrated how each team’s processes vary from others.
This resulted in differences in anatomical and mechanical representations of tissue structures and, most
importantly, simulation predictions. In the proposed project, we first aim to determine consensus workflows that
represent good practices in computational knee biomechanics. Consensus will be established specific to a
diverse set of model contexts of use as credibility frameworks already acknowledge the dependence of the depth
and intensity of modeling activities on the intended use of models. Context of use also dictates the fidelity of the
model, the amount of data to build the model and validate its predictions, computing resources, and subject-
specificity. Consensus building will be facilitated by the Delphi method, which will provide the means for a
structured and iterative outreach to the knee modeling experts worldwide. In the second aim, the reproducibility
and accuracy of context relevant consensus workflows will be tested against required resolution of simulation
outputs. Five teams will develop models and conduct simulations using the same data, with the same intent, and
this time, relying on the same modeling and simulation workflow. Documented and disseminated consensus
workflows, including outcomes and by-products of use cases, will unify, and possibly standardize, the highly
fragmented ecosystem of knee modeling approaches. Subsequently, they will enable multi-site, large scale, and
dependable in silico trials in knee biomechanics.

Public health relevance
PROJECT NARRATIVE Computational modeling is an enabling technology for scientific discovery and clinical care but the potential of simulations in knee biomechanics is hampered by the diversity and ambiguity of modelers’ preferences. Consensus-based workflows, which are established and evaluated for intended uses of knee models, are sorely needed to elevate knee modeling and simulation as an efficient, reliable, and scalable practice. With these, modelers will be empowered to confidently conduct large scale virtual cohort studies and routine individualized simulations that are unified across research institutions and healthcare settings.